GATA Factor Mechanisms in Erythroid Regeneration

ABSTRACT
Erythropoiesis, the production of red blood cells (RBCs), is fine-tuned to meet physiological demands. During
regeneration or “stress erythropoiesis” caused by anemia, a subset of genes and proteins are upregulated in
association with an increased rate of RBC production. A critical gap in understanding erythroid regeneration
hinges on whether the activation of gene regulatory networks in erythroid progenitors (driven by transcription
factors) are stress-specific or represent broader control mechanisms in other contexts. Moreover, the underlying
etiologies in which the erythroid system loses its ability to regenerate in chronic anemias are often unclear. We
discovered that the Sterile Alpha Motif Domain-14 (Samd14) gene is elevated in models of acute/chronic anemia.
Samd14 is regulated by the transcription factor GATA2, which coordinates a network of genes with critical
functions in hematopoiesis and hematologic disease. The GATA2-occupied Samd14 cis-element (Samd14-Enh)
is required for survival in a model of hemolytic anemia, but dispensable for steady state erythropoiesis. Erythroid
progenitors lacking Samd14-Enh have impaired c-Kit signaling, a quintessential pathway regulating
hematopoiesis and erythropoiesis. These results reveal the involvement of a GATA2-Samd14-c-Kit regulatory
axis in erythroid regeneration. Whereas SAM domain-containing proteins are involved in hematopoiesis and cell
signaling, and several are upregulated in anemia, their mechanisms of action are not well understood. Our data
suggests additional cohorts of enhancers with properties mimicking the Samd14-Enh are anemia-regulated. We
hypothesize that Samd14 and additional GATA2 and Regeneration-Activated (G2R) enhancers control erythroid
regeneration. In Aim 1, mechanistic analyses in human and mouse will define Samd14 requirements for cell
signaling and survival of erythroid progenitors. Aim 2 will delineate a GATA2 and anemia-regulated (G2R) gene
network governing a sector of the complex biology surrounding anemia responses. Approaches using primary
human/mouse cells and innovative mouse genetic model approaches will test SAMD14 mechanisms (and other
SAM domain proteins) in c-Kit signaling and erythroid regeneration. These aims will establish valuable contrasts
between homeostatic and regenerative erythropoietic mechanisms, enhancer knockout and gene knockout
phenotypes, and between functionally-distinct cis-elements which contain similar sequence and molecular
properties. By elucidating a GATA2-Samd14-c-Kit axis in acute anemia, and global/locus-specific GATA2
mechanisms of Samd14-Enh-like cis-elements, we expect these studies will reveal fundamental gene regulatory
mechanisms in erythroid regeneration with implications in hematologic disease, including anemias.

Public health relevance
PROJECT NARRATIVE We discovered a new constituent of the quintessential SCF/c-Kit signaling pathway, Samd14, regulates erythroid progenitor function during regeneration. This project will advance our mechanistic understanding of the relationship between Samd14 and SCF/c-Kit signaling in erythroid regeneration, and establish completely unique stress-responsive mechanisms, with potentially-important therapeutic implications.